Cellular and Molecular Geroscience CoBRE: Phase 2

ABSTRACT
Impressive advances have occurred in our understanding of the molecular and cellular mechanisms of aging,
including the discovery of interventions that delay aging and increase healthspan. Importantly, these
interventions also have a profound impact on the incidence of age-related disease. These findings provide
compelling evidence that multiple human diseases share a common mechanism - aging. This is the basis of
geroscience-related studies and the focus of this application. The outcome of the initial CoBRE investment in
Phase 1 resulted in independent NIH funding for 75% of the original RPLs and 100% of the PPLs. This overall
83% success rate resulted in new funding of $20,881,036 to geroscience investigators (181% return on
investment to date) and 122 publications. As a result, two additional RPLs were recruited to our CoBRE during
Phase 1 and are part of this competitive renewal. The Phase 2 CoBRE described in this application builds on
the previous successes and expands our research base to create a dynamic, interdisciplinary, inter-departmental
program on our campus. Our highly successful, well-established scientific experts who are currently studying
mechanisms of aging and/or age-related disease will continue to mentor our RPLs and PPLs to synergize both
the quantity and quality of research in the context of the aging organism. Additional RPLs are being recruited.
All current and previous RPLs/PPLs benefit from the resources of the Oklahoma Nathan Shock Center and
mentor graduate students and fellows and work interactively with our NIH Geroscience T32 Training grant. Thus,
a dynamic, sustainable, and interdisciplinary Geroscience Research Program has emerged on the OUHSC
campus based in large part due to CoBRE funding. Our goal is to continue to evolve the program into the Center
for Geroscience and Healthy Brain Aging and a) produce a new generation of collaborative Geroscience-trained
researchers who will continue to build OUHSC and Oklahoma as a leader in Geroscience research, b) integrate
and improve the quality and quantity of Geroscience research at OUHSC, and c) increase the long-term growth
of NIH competitive funding throughout Oklahoma. Our specific goals for the Phase 2 Cellular and Molecular
Geroscience CoBRE are to: 1. Continue to build on the successes in Phase 1 and expand biomedical research
in Geroscience through the mentoring of RPLs/PPLs by highly experienced, dedicated senior investigators, 2.
Enhance the infrastructure critical for expanding Geroscience research, 3. Foster collegial, collaborative, and
productive relationships among CoBRE investigators and other scientists, and 4. Establish milestones and
expectations that ensure the success of the program and its participants. The expansion of geroscience expertise
is fundamentally important for the advancement of scientific research since failure to understand the
development and effects of disease in the context/milieu where it normally develops (the aging organism)
compromises the success of translational research and clinical trials research.

Public health relevance
NARRATIVE The cellular/molecular events that occur within the aging organism contribute to an environment that allows disease to develop - this is the basis of geroscience-related studies and the focus of our application. Our program has had outstanding success, resulting in a return on investment of 181%, and dramatically expanded expertise in Geroscience research at the University of Oklahoma Health Sciences Center. Our Phase 2 CoBRE program is designed to build on this success and develop a rigorous geroscience research program in Oklahoma.